Collaborative Approach to Reach Everyone with Familial Hypercholesterolemia: CARE-FH

PROJECT SUMMARY
Familial hypercholesterolemia (FH) is a common genetic disorder (prevalence 1 in 250) that requires lifelong
sustained medical care. Evidence-based guidelines for screening and treatment for FH exist. These include
universal screening of children ages 9-11, of adolescents ages 18-20, and of adults ages 40 and above;
approved diagnostic tools including lipid panels and genetic testing; and recommendations for initiation of lipid
lowering medication. FH diagnosis is currently made too late in life, often after a premature heart attack has
occurred creating a care gap that results in excess cardiovascular morbidity and mortality. Diagnosing FH in
the primary care setting would optimize treatment for individuals with FH and close this care gap. Utilizing tools
from implementation science and human centered design, and by considering uptake, acceptability, and
sustainability of programs related to FH care should improve earlier diagnosis. Implementation strategies that
include insights from patients, clinicians, and healthcare systems are necessary. Our long-term goal is to
create an effective FH diagnosis program that is practical and sustainable in the real-world setting. The main
objective of this project is to determine the uptake of an FH diagnosis program integrated into primary care
practices to promote early identification of adult and pediatric patients that is generalizable to other healthcare
settings. Our research question is, does using a multi-level implementation strategy package, designed to
address the specific needs of patients, clinicians, and healthcare systems, improve the diagnosis and
activation of care management for individuals with FH. Our specific aims are to: 1) to design a clinical trial to
assess multi-level implementation strategies for improving FH diagnosis in an integrated health system, 2)
compare FH diagnosis rates among primary care clinicians who receive the implementation strategy package
versus those who do not, 3) to measure implementation success of an organized FH diagnosis program, and
4) to explore patient-related service and health outcomes related to an FH diagnosis program.

Public health relevance
PROJECT NARRATIVE Diagnosis rates of familial hypercholesterolemia (FH) are low in the United States, despite multiple guidelines and recommendations for screening and treatment of high cholesterol, to prevent heart attacks in those affected. Using a stepped-wedge design, we plan to utilize tools from implementation science to improve uptake, acceptability, and sustainability of FH diagnostic programs in primary care settings. If successful, this study will provide tools generalizable to other health care systems to improve FH diagnosis rates.